Computational Modeling Core

SUMMARY/ABSTRACT
The Computational & Predictive Modeling Core (CPM) will provide state-of-the-art machine learning and
data integration methodologies to enable the analysis, interpretation, and predictive modeling of the data
created within the other Cores and Projects. To accomplish this, the Core will: (i) develop novel computational
modeling frameworks towards predictive modeling of physiological processes with a multi-scale understanding
of outcomes, (ii) adapt and combine existing analysis techniques for use in the proposed studies, and (iii) work
closely with the other investigators to apply and then interpret the analysis results derived during the proposed
studies. A particular focus of the Core’s new methodologic development and modeling applications will be
multi-omic data integration across three dimensions: between molecular profiling technologies, across cohort
studies, and between experimental models and human infection. These activities will occur in close
collaboration with each Project, as evidenced by the Core’s involvement in nearly every Aim of the proposal.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus and Candida albicans are both organisms that are commonly found on healthy individuals without causing problems but lead to deadly infections in some. The Computational & Predictive Modeling Core will lead the development of new computational algorithms for pattern matching across datasets, to identify commonalities across different types of measurements and between both types of infections. Doing so will improve our ability to predict the outcome of infection and our understanding of how these infections become life-threatening.